Capturing the molecular complexity of tau pathology-associated proteomes involved in the etiology of Alzheimer's disease and related dementias

PROJECT SUMMARY/ABSTRACT
The goal of this project is to capture the molecular complexity of pathological tau-associated proteins in the
brain of Alzheimer’s disease (AD) and related tauopathy patients via proximity-proteomics and gain a thorough
mechanistic understanding of their role in the progression of tau pathology and associated neurodegeneration.
Previous studies suggest a correlation of characteristic temporal and topological patterns of microtubule-
associated protein tau (MAPT) aggregates with the observed clinical phenotype and the progression of the
disease. Although neurofibrillary tangles (NFTs) and other forms of phospho-tau aggregates are believed to
play a pivotal role in the disease process, we have a poor understanding of the composition and molecular
environment of these insoluble aggregates, and how their formation, toxicity, and spread across the brain
regions is regulated. A better understanding of the phospho-tau interactome in AD and primary tauopathies,
and how these proteins regulate the oligomerization, pathological accumulation, and seeding of tau in affected
neurons and glia is of critical importance for the identification of novel therapeutic targets.
As a limitation of current technologies, the in-depth characterization of NFTs and other neuropathologic
inclusions has historically been difficult to address, since these aggregates are detergent-insoluble, and thus
refractory to classical affinity purification methods. To address this limitation, we have established a novel
method for the proximity-labeling, purification and identification of pathological phospho-tau associated
proteins from fixed human tissue followed by quantitative proteomics analysis.
We hypothesize that the molecular environment of pathological tau aggregates contributes to the AD
disease process and propose to use the latest cutting-edge technologies to determine and compare the
phospho-tau associated proteome across different patient cohorts and disease stages, to decipher molecular
signaling networks in disease development, and to functionally validate novel therapeutic targets in human AD
cases, mouse models, and human organoid models. Our three specific aims are: (i) to compare tau pathology-
associated proteomes across common tauopathies via proximity proteomics of phospho-tau inclusions in the
brain of AD and primary tauopathy patients, (ii) to establish spatiotemporal patterns of tau pathology-
associated proteomes specific for disease stages, brain regions, and brain resilience in AD patient cohorts,
and (iii) to determine the functional role of tau pathology-associated proteins in neurodegenerative processes
in human AD cases, mouse models, and human brain organoids.
Successful completion of this project will identify novel molecular components and cellular pathways
regulating the pathogenesis of AD and primary tauopathies, which may provide new therapeutic strategies for
effective treatment of these devastating disorders.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease (AD) is the most common form of dementia and a leading cause of death in the United States. We propose to use the latest technologies to determine the molecular composition of disease- causing protein aggregates in human patient brain tissue. Potential modifiers of the disease process will be further investigated in functional studies using mouse models and advanced cell culture models of AD.